Development of a novel dual inhibitor for treatment of MYCN-amplified neuroblastoma

PROJECT SUMMARY/ABSTRACT
Neuroblastoma is the most common extracranial tumor occurring in childhood with the majority of patients
being under five years old. High-risk cases of neuroblastoma are associated with amplification of the MYCN
oncogene, an event that occurs in ~50% of all high-risk situations and results in poor overall survival despite
aggressive multimodal therapies. MYCN encodes the transcription factor N-MYC, which like any MYC
protein functions to regulate expression of thousands of genes involved in multiple biological processes.
The ability of any MYC protein to drive cancerous gene expression is dependent on the cofactor interactions
that MYC makes to sculpt the transcriptome towards tumor formation. Because direct targeting of MYC
proteins has proved to be challenging, an alternative approach to inhibit MYC has arose that is based on
identifying important MYC cofactors that have surfaces amenable to small molecule inhibition and focusing
drug discovery efforts on those cofactors as a means to disable MYC function. Two N-MYC cofactors that
are viable candidates for this approach in MYCN-amplified neuroblastoma are WDR5 and G9a. In these
cancers, my group pioneered the idea to inhibit N-MYC function through our studies on WDR5. The work of
our lab and others support the essential role of WDR5 as a direct N-MYC cofactor that facilitates
recruitment of N-MYC to promoters of genes involved in the ability of N-MYC to push abnormal cell growth
and division. Also in MYCN-amplified NB, evidence indicates that G9a is a N-MYC cofactor that is recruited
by N-MYC to enhancers of genes that contribute to cell differentiation, effectively repressing expression of
differentiation genes and thus permitting N-MYC to drive an oncogenic gene expression program. While
development of small molecules that target either WDR5 or G9a alone have continued to advance,
resistance mechanisms and drug development issues associated with single-agent treatment are already
surfacing. The premise of this project is based on the idea that to disable a larger portion of N-MYC function
—and overcome any drug development issues—these cofactors should be inhibited together and if possible
through a single molecule. Therefore, the goal of this project is to move WDR5 and G9a into the focus of
novel drug discovery efforts through a combination of chromatin-focused studies and pursuit of dual
inhibitors that can target both proteins. Specific Aim 1 will employ genetic, genomic, and chemical biology
approaches to identify the genes that are bound and regulated by N-MYC, WDR5, G9a, and determine how
combined inhibition impacts N-MYC-dependent transcription. Specific Aim 2 will challenge the notion that
dual inhibition is possible by using computationally-driven drug discovery to identify and screen potential
chemicals that can inhibit WDR5 and G9a together. At the completion of these studies we will have
comprehensively detailed the role of WDR5 and G9a in MYCN-amplified neuroblastoma and evaluated dual
inhibition of WDR5 and G9a as a potential therapeutic strategy to block N-MYC function.

Public health relevance
PROJECT NARRATIVE Amplification of the MYCN gene, which encodes the N-MYC transcription factor, is associated with high-risk cases of neuroblastoma and is correlated with poor overall survival rates. This proposal has been designed to explore if N-MYC function can be disabled through targeted inhibition of two important N-MYC cofactors: WDR5 and G9a. Completion of this work will challenge the significance of WDR5 and G9a in MYCN- amplified neuroblastoma, while evaluating the impact of targeting WDR5 and G9a either alone, in combination, or simultaneously.